Surgery / Physiology Core

Core C will continue to provide key animal models necessary for the studies of ERK
signaling, miR 17-19 cluster biology, and matrix and mechanotransduction in arteriogenesis, and to facilitate
evaluation and validation of discovery research carried out in the PPG projects. To this end, the Core has
established 64 types of surgical animal models of human diseases. To meet the evolving needs of the
program, we are introducing six mouse models including mouse hindlimb ischemia, stroke, Matrigel plug
assay, skin wound healing, partial carotid ligation and cornea pocket assay. The Core is supported by 3 microsurgeons
with extensive microsurgery techniques experience and 2 technologists with experiences in animal
care and handling under the direction of Dr. Zhang. These standardized efforts will result in facilitating the
translation of ideas from the bench to mice, and ultimately to humans.

Public health relevance
Well-designed surgical animal models have been vital to examination of signaling pathways and mechanisms of disease, developing diagnostics and discovering efficient drugs and tailor therapeutic applications. Core C will contribute significantly to the probability of success of the program by providing key animal models necessary for execution of the PPG projects